Therapeutic Disruption of HIV Transcription by HIV-1 Tat Protein-Degrading Molecules

Abstract
Despite effective antireroviral therapy (ART) suppression of HIV-1 replication to below the detection limit, latent
proviruses can reinitiate viral production upon cell stimulation or treatment interruption. The HIV-1 Tat protein
plays a pivotal role in regulating the transition between viral latency and active replication, enhancing transcript
elongation from the HIV-1 promoter through a positive feedback mechanism. Tat inhibitors hold exceptional
promise due to several reasons: 1) Tat is expressed early in the virus replication cycle; 2) No homologs of Tat
exist in host cells; 3) Inhibition of Tat disrupts the essential positive transactivation feedback loop required for
viral activation; 4) Disruption of this loop leads to epigenetic modifications at the HIV promoter, thus stably
repressing viral reactivation. Tat also causes neurotoxicity and disrupts the blood-brain barrier causing
neuroinflammation. Consequently, there is considerable interest in developing Tat inhibitors to complement ART.
Furthermore, the block-and-lock HIV functional cure strategy relies on specific HIV transcriptional inhibitors
to promote epigenetic silencing of proviral expression, locking the virus in a profound state of latency, from which
reactivation is highly improbable post-ART interruption. This principle was demonstrated with the Tat inhibitor
didehydro-Cortistatin A (dCA); however, clinical studies are pending due to dCA’s complex structure and costly
synthesis. Therefore, additional structurally distinct candidates with equivalent bioactivity are essential
in the pre-clinical pipeline. To discover novel Tat inhibitors with more cost-effective and simpler synthesis
paths, we conducted a cell based high-throughput screening of several compound libraries. Using counter-
screens and multiple orthogonal techniques to exclude non-specific and toxic molecules, we identified three
small molecules with a therapeutic index (TI) greater than 10 and favorable chemical properties. Interestingly,
all three compounds uniquely promote Tat protein degradation by activating the ubiquitin-proteasome
pathway, effectively functioning as molecular glues. Here, we propose to carry out hit-to-lead validation and
characterization, following a logical pathway for compound progression. The synthesis of novel analogs in each
series, utilizing both traditional medicinal chemistry techniques and computational molecular dynamics, will be
carried out by Dr. Bannister's medicinal chemistry group at UF Scripps. The structure-activity relationship (SAR)
studies will be conducted collaboratively by the medicinal chemists and Dr. Valente’s virology group. Dr. Valente
will evaluate the anti-HIV activity in human primary cells and conduct in depth characterization of the mechanism
of action (MOA) of all the top-performing compounds. Additionally, ADME studies will be carried out by Dr.
Cameron’s group at UF Scripps, and the antiviral efficacy of the compounds will be assessed using humanized
mouse models of HIV infection in Dr. Garcia’s laboratory at the University of Alabama. At the conclusion of
this study, we expect to have specific Tat inhibitors/degraders with good metabolic and pharmacokinetic
properties that prove highly effective in reducing HIV transcription in studies involving humanized mice.

Public health relevance
Project Narrative HIV transcription is regulated by the HIV Tat protein, but Tat inhibitors are not yet part of the clinical antiretroviral ammunition despite their immense potential at shutting down particle production from infected cells and blocking Tat toxicity. A high throughput drug screening of 369,203 compounds yielded three strong leads with the unique property of degrading the Tat protein. We now propose to develop improved compounds through medicinal chemistry, characterize, and tested them in animal models of HIV infection to expand our panel of Tat inhibitors for commercialization of this unique class drugs.